Enolase inhibitors as therapeutic leads for Naegleria fowleri infections

Project Summary
Human infection by the pathogenic free-living amoeba Naegleria fowleri causes primary
amebic meningoencephalitis (PAM), which in the majority (>95%) of infections end in
fatality. We have recently found that a group of phosphonate inhibitors of the glycolytic
enzyme enolase (ENO) that are well-tolerated in mammals are potent anti-amebic
compounds. The goal of this proposal is to test the hypothesis that the amoeba ENO
(NfENO) is a promising target for therapeutic development and to optimize phosphonate
inhibtors to early lead stage. As part of this, we will use a small collection of inhibitors and a
series of orthologous assays to biochemically validate NfENO as target of the agents and
will determine the effect of the inhibitors on amoebae infections in a rodent disease model,
scoring the immune response to treatment as part of the effort.

Public health relevance
PROJECT NARRATIVE Work proposed here will explore the activity of a promising metabolic inhibitor against the amoebae, defining the suspected cellular target, testing new analogs of the parent inhibitor, and assessing the impact of the agent in a rodent model of disease. The described work is the first step in maturing the compounds into treatment of pathogenic free-living amoebae Naegleria fowleri infection. We will use a combination of biochemical, medicinal chemical, and model animal experiments to score the impact of enolase inhibitors developed for use in humans against the amoebae and to assess the role of the immune system in the treatment regime.